Translational Biology Core

Project Abstract (Core B)
In this revised application, modifications from the previous submission are marked in blue.
Core B is designed to provide support to the projects by standardizing common methods and resources, ensuring
consistency and quantitative accuracy across the Program Project. Each service of the Core is relevant to and
will be utilized by each project. In addition to providing state-of-the-art preclinical radiotherapy and histopathology
services in order to bring accurate and reproducible methodology across the program project, we will also
leverage the data generated in this effort in order to develop automated target delineation and treatment planning
algorithms using machine learning and artificial intelligence approaches. The goals of Core B are fourfold, and
encompass both service and technique development efforts:
Specific Aim 1: Treat tumors and normal tissues in small animals with radiation using clinically relevant
conformal image-guided techniques.
Specific Aim 2: Utilize artificial intelligence and machine learning techniques to automate tissue and tumor
segmentation and radiation treatment plan definition.
Specific Aim 3: Perform histopathologic analysis of tissue specimens collected from experimental subjects.
Specific Aim 4: Provide a centralized repository of cell lines, animal strains, media, and serum for each
project.

Public health relevance
Project Narrative (Core B) Core B, the Translational Biology core of this program project, provides support to the projects for the execution of common methods including animal radiotherapy and histopathological analysis maintenance and for standardization of cell lines and shared resources. It is also responsible for development of improved methods for target identification and treatment planning to improve the accuracy and reproducibility of small animal irradiation. These are essential services that are common to all projects.